A Nursing Program for Advancing Training in Health and Social Determinants (N-PATHS)

PROJECT SUMMARY/ABSTRACT
The N-PATHS (Nursing Program for Advancing Training in Health and Social Determinants) program is a
comprehensive and immersive research training program consisting of three main components, 1) in-person
intensive and 2) monthly learning modules (asynchronous) and webinars (synchronous), and 3) mentorship
(i.e., mentored-research experiences). The goal of the program is to bring together nurse scientists and allied
scientists for collaboration and learning experiences to improve their understanding of social determinants of
health (SDOH) concepts and methodology and acquire skills to conduct and disseminate SDOH and health
equity research. The overall objectives of the program are to: 1) Enhance participant knowledge and
understanding of SDOH frameworks and concepts, 2) Strengthen participant’s capacity and skills to apply
SDOH concepts in the design, analysis, dissemination, and implementation of research, 3) Expand the volume
and quality of nurse-led research focused on health equity and SDOH through dissemination of research
findings. This 10-month program begins with an in-person intensive to foster relationships and connection to
facilitate learning from diverse perspectives. Then, participants will engage in monthly webinars and
mentorship (synchronous) and online self-paced learning modules (asynchronous) to facilitate further
knowledge acquisition in SDOH concepts and skill development in research through mentored-research
experiences. This program is designed for nurse scientists – those with a degree in nursing – and scientists in
aligned professions, who are interested in conducting SDOH research. Program curriculum will be developed
by the program faculty and reviewed by an advisory committee, who will provide feedback on program
processes and content. The proposed timeline for N-PATHS includes curriculum and website development
along with recruitment of participants in year 1 and then dissemination of the N-PATHS research training
program in years 2 & 3.

Public health relevance
PROJECT NARRATIVE The N-PATHS (Nursing Program for Advancing Training in Health and Social Determinants) program is envisioned as a research training program to enrich nurse scientists' understanding and application of social determinants of health into research. This program aims to enhance knowledge, integrate SDOH into nursing research, and translate findings into practice and policy, thereby contributing to the improvement of equity for all. This comprehensive and immersive program includes in-person networking, didactic lectures, webinars, community engagement, and mentorship with the goal of nurturing skills in SDOH research design, analysis, and dissemination.